Administrative Core (Core A)

ABSTRACT – CORE A
The Administrative Core (Core A) will be the central hub of our UCSF Stanford Endometriosis Center for
Discovery, Innovation, Training and Community Outreach (ENACT). It will provide administrative, financial, and
organizational support for the investigators and technical staff engaged in our ENACT Center's research projects
and the Educational and Community Outreach Core. Day-to-day operation of the Administrative Core will involve
coordinating all administrative, financial, and compliance aspects of the award to ensure that expenditures are
consistent with the intent of the award and the guidelines and regulations that govern the use of funds, as well
as any institutional and federal requirements, and that Project and Core goals are met. The Core will be co-led
by Linda Giudice, MD, PhD (UCSF) and David Stevenson, MD (Stanford) who both have extensive experience in
translational and clinical investigation and in administering large, complex, multi-disciplinary research programs.
They will oversee the Core A Program Administrator and all Core operations and functions and will liaise with the
UCSF Department of Obstetrics, Gynecology and Reproductive Sciences (OBGYN/RS) Research Administration
Office for post-award accounting and with comparable staff at Stanford. This administrative structure has been
devised to assure achieving research and educational goals, financial accountability and research compliance for
all Projects and Cores across both institutions and with collaborating subcontractors. Located in the UCSF Center
for Reproductive Sciences administrative office, Core A will organize monthly ENACT Steering Committee
meetings, Advisory Board meetings, and participate in the planning, advertising and operationalizing of the
annual UCSF Center for Reproductive Sciences (CRS) retreat that includes investigators and trainees across the
Bay Area to share their research and identify and nurture new talent. Core A will provide infrastructure support
for Core B (education/outreach) and the Projects and liaise with underserved minority students and programs
for opportunities in our P01 labs. It will establish a website and facilitate social media and other communications
to showcase our innovative research programs, their clinical relevance, and opportunities for trainees and women
in our community to engage in the ENACT Center focused on endometriosis research and patient empowerment.